Parent-Mediated Teleheath Intervention for Insomnia in Young Autistic Children

Abstract
Insomnia is a common complaint in young children with autism spectrum disorder (ASD, autism). Across a
range from mild to severe, insomnia affects as many as 40-80% in this population.7, 9-11 Insomnia is
characterized by problems of initiating sleep and/or maintaining sleep occurring three or more nights per week
for > three months accompanied by distress, impairment or both.12 The diagnostic criteria stipulate that the
sleep problem is not attributable to another cause. In autistic children, insomnia may interfere with
concentration and learning, may contribute to daytime sleepiness, disruptive daytime behavior, emotion
dysregulation and physical injury.13, 14 The child’s bedtime and sleep disturbances may also interfere with sleep
for caregivers or other family members and predict elevated parental stress.15-20 Chronic insomnia in children
may have detrimental effects on cardiovascular, endocrine or immune systems.21, 22 Parents of autistic children
and insomnia consistently report bedtime resistance behaviors that may be difficult to manage. Accumulating
data indicate that parent-mediated behavioral interventions for insomnia can be effective.23 To date, however,
only a few randomized controlled trials have rigorously tested parent-mediated behavioral interventions for
insomnia in autistic children.7, 24-27 Following on the results of our prior trial that delivered parent mediated
treatment via telehealth4, we propose a large scale, multisite telehealth trial of a structured parent-mediated
behavioral intervention for insomnia.
This five-year, three-site telehealth randomized trial will evaluate a structured, parent-mediated behavioral
intervention for insomnia compared to up-to-date parent education. Autistic children (N=180, ages > 3 to 7-11
months years, with moderate or greater insomnia will be randomly assigned to a structured, 5-session sleep
parent mediated treatment (SPT) program delivered over 10 weeks or 5 sessions of sleep parent education
(SPE) over 10 weeks. Assessments and treatments will be delivered via telehealth. In our recently completed
telehealth trial, SPT was superior to SPE in improved child sleep outcomes, parental self-efficacy and
parental distress.4 Although encouraging, the sample size of this recent study provided limited exploration of
a number of variables and of treatment moderators. We now propose a large-scale definitive study of
telehealth SPT versus individualized, menu-driven SPE. Pre-specified moderators include, arousal, anxiety,
behavioral rigidity, sensory sensitivity. irritability, hyperactivity, and adaptive behavior. Examination of
moderators will help answer “who” this intervention works for. Importantly, we will use a newly developed and
validated outcome measure designed specifically for insomnia in young people with ASD. Children in the SPT
group will be assessed at 20 weeks post-treatment to evaluate durability. Parents of children initially
randomized to SPE will be offered SPT after the 10-week endpoint. A successful parent-mediated behavioral
intervention for insomnia in young autistic children delivered via telehealth in the home could change the
standard of care, change the course of long-term detrimental effects of insomnia for child and parents,
and promote broader implementation. The time is right for this definitive trial.

Public health relevance
Project Narrative Co-occurring insomnia is present in 40-80% of autistic children, yet evidence-based options are limited. This large scale, three-site study will evaluate a structured, parent-mediated behavioral intervention for insomnia delivered via telehealth in the home in autistic children ages of 3-7 of years compared to an active control.